Functional protein disorder in intracellular transport

Project Summary
The
complex organization. A
human cell efficiently yet correctly distributes intracellular content
detailed understanding of the transport mechanism is vital to understand
despite its large size and
neurodevelopmental and neurodegenerative pathologies. Dedicated kinesin and dynein motor
protein complexes walk along microtubules for directional transport of cargoes such as organelles
and vesicles, kinetochore, or ribonucleoproteins.
involved i
structura
sufficient
Many functionally relevant segments of proteins
n this transport are structurally disordered regions (IDRs) such that static average
l models provided by cryoEM or artificial intelligence-based structure prediction are not
to understand the protein function.Our overarching mission is to tap into unexplored
aspects of our understanding of the structure/function relationships in cargo transport in human
cells. In this proposal, we ask:
spectrum?
1) How can a single cytoplasmic dynein cover its entire functional
There is only one major form of cytoplasmic dynein. Itsspecificities are partly due to
a variety of cargo-specific motor adaptors, all of which contain IDRs, and the regulatory role of
phosphorylation. Dyneinmis-regulation has been implicated in various nervous system disorders
and colon cancer. We will reveal the mechanistic basis and functional implications of dynein
specificity factors with a special focus on the dynein light intermediate chain (LIC), another IDR.
We will also elucidate the role of the cell regulator Pin1, shown to have high interdomain flexibility,
in interactions between LIC and the dynein adaptors.
Olduvai
2) How does kinesin KIF5A regulation by
protein impact human brain development? Olduvai domains are encoded by
Neuroblastoma Breaking Point Family proteins and show the largest human-specific increase in
copy number of any protein coding region in the genome. This increase is linked to brain size
growth, but also to schizophrenia and autism. To date, the molecular mechanisms underlying
these functions are entirely unknown. We will show how Olduvai domains, while being IDRs, act
through modulation of kinesin KIF5A-driven transport, which occurs predominantly in neurons.
For these studies, our tools are nuclear magnetic resonance (NMR), uniquely suited to study
IDRs, supplemented with other biophysical methods to probe structure, dynamics, and
interactions of proteins involved in transport, and in vitro motility and cell-based assays to study
resulting functions. We will build on our 20+ years of NMR expertise, previous work on LIC-
adaptor interaction and on allostery in Pin1, and foundational work on Olduvai domains. We
anticipate that our work will inspire new questions about regulation of dynein transport and
establish the molecular link between intracellular transport, Olduvai copy surge and brain disease.

Public health relevance
Project Narrative Numerous disordered segments of the proteins involved in the kinesin and dynein motors for intracellular cargo transport are functionally relevant and crucial for understanding brain and neurodegenerative diseases. Focusing specifically on such proteins, our aim is to how dynein achieves its exceptionally broad functional spectrum and elucidate how human lineage-specific Olduvai domains regulate kinesin- driven transport to impact brain development. Our tools are NMR methods to probe structure, dynamics, and interactions of the proteins of interest, complemented by in vitro motility and cell-based assays to explore their functional implications.